Urban Air Pollution and Alzheimer's Disease: Risk, Heterogeneity, and Mechanisms

Our overarching goal is to further resolve the neurodegenerative role of traffic-related air pollutants (TRAP), a
ubiquitous exposure in urban areas where most older Americans reside. Our recently published epidemiologic
data showed strong association between elevated PM2.5 (particulate matter <2.5µm) and increased dementia
risk in women >65 years, with a bias for ApoE4 homozygotes (JC Chen in Cacciottolo et al 2017, PMID
28140404). In this same report, experimental studies of female mice from the Finch-Sioutas Labs showed
that exposure to nPM (a nano-sized subfraction of TRAP) was pro-amyloidogenic with an ApoE4 bias. Other
changes include attrition of hippocampal CA1 neurites and myelin, which model selective damage in AD and
cerebral ischemia. In a mouse stroke model, nPM exposure exacerbated cerebral ischemic damage (William
Mack: Liu et al 2016, PMID 27071057). Differences by sex and ApoE alleles suggest sources of heterogeneity
in human responses to TRAP.
We propose four projects: epidemiological studies of two nationwide cohorts of women (Project 1, JC
Chen: Women's Health Initiative Memory Studies; WHIMS) and men (Project 2, C Franz and W Kremen:
Vietnam Era Twin Study of Aging, VETSA) and two experimental studies of air pollution exposure (Project 3,
Finch: mouse models of aging and AD; Project 4 Wm Mack, chronic ceebral hypoperfusion). These projects
address a common set of questions: (1) What is the AD risk imposed by TRAP and does the associated risk
vary by sex, life stage, and APOE/other alleles? (2) What neurodegenerative changes are induced by TRAP
and what is the resulting risk for early cognitive decline of AD? (3) Which brain pathways are most susceptible
to TRAP neurotoxicity? (4) Do shared mechanisms (e.g., amyloidogenesis, cerebrovascular damage and
hypoperfusion, and neuroinflammation) predispose to premature cognitive decline and an increased AD risk?
Two supporting Cores provide population neuroinformatics, neuroimaging of blood-brain-barrier (BBB) and
myelinated tracts, large-scale air pollution modeling and epidemiology, inhalation exposure assessment and
neurotoxicology. Neuroimaging Core B1 provides human brain imaging harmonized across sites and
mediation analyses (Projects1-2). B2 provides high-resolution imaging of BBB and tractography for mouse
models (Projects 3-4). Core C Environmental Exposure and Neurotoxicology subcore C1 harmonizes
population exposure estimates for WHIMS and VETSA (Projects1-2); C2 provides inhalation exposure of mice
for studies of sex and ApoE allele responses (Project 3) and of chronic cerebral hypoperfusion (Project 4); C3
analyzes brain inflammatory protein responses to TRAP. For P01 integration, the Administrative Core builds
on the infrastructure of AirPollBrain (led by Finch& Chen), a USC-funded collaborative network since 2010.
Results of this program will advance understanding of TRAP contributions to AD risk and accelerated cognitive
decline, and provide a rationale for preventive intervention in the environmental neurotoxicology of AD.

Public health relevance
Relevance to Public Health [revised] The brain is vulnerable to air pollution. A multi-disciplinary and multi-institutional team from the University of Southern California and their collaborators will study how traffic-related air pollution (TRAP) from metropolitan areas where most older Americans reside contributes to accelerated brain aging and risk of dementia. In the next 5 years, the team will study human populations and experimental models to examine the brain pathways that are specific for Alzheimer disease for gender and age differences in vulnerability to TRAP. These studies address the neglected role of common environmental neurotoxins in the development of Alzheimer disease and interactions with Alzheimer risk genes.